Next-generation ultrafast functional 3D pulmonary imaging

PROJECT SUMMARY
Deadly diseases such as COPD, asthma, lung injury, constrictive bronchiolitis, and pulmonary fibrosis affect
>300 million people worldwide and cause ~3 million annual deaths. There is currently no widespread clinical
imaging modality to perform high-resolution functional lung imaging: CT, conventional MRI, and X-ray can only
provide structural images of dense tissues—informing about pathologies like tumors and pneumonia—but
yielding little or no information about lung ventilation, perfusion, alveoli size, etc. This state of affairs contrasts
with cancer imaging, which includes MRI, CT, ultrasound, mammography, PET and others, which collectively
enable early detection (via population screening), diagnoses, and monitoring response to treatment.
Furthermore, CT scans expose the body to ionizing radiation, and thus cannot be performed frequently due to
increased risk associated with cancer-inducing radiation. MRI of hyperpolarized noble gases (e.g. 129Xe) reports
on lung function: ventilation and diffusion. Despite remarkable research breakthroughs in this field demonstrating
the effectiveness and safety of hyperpolarized noble gas MRI to detect a wide range of lung diseases and monitor
response to treatment, the prospects for widespread clinical adaptation of this imaging modality face major
challenges, including (i) the high cost and complexity of the equipment for production of hyperpolarized 129Xe
gas, and (ii) the requirement for a customized MRI scanner capable of 129Xe – note, all FDA-approved MRI
scanners can image only protons. We have developed clinical-scale production of proton-hyperpolarized
propane gas. The process of hyperpolarized propane gas production is remarkably simple, highly efficient and
low-cost. A dose of contrast agents can be prepared in 2 seconds using disposable hyperpolarizer. Moreover,
propane is already FDA-approved for unlimited safe use in foods. Therefore, hyperpolarized propane lung MRI
can obviate the challenges of hyperpolarized 129Xe gas. Under this training award, I will be trained to develop
next-generation 3D ultra-fast lung imaging capability using three spin isomers of hyperpolarized propane gas. I
hypothesize that it may be possible to create highly symmetric hyperpolarized propane spin isomer capable of
retaining hyperpolarized state for ~1 minute in the gas phase at clinically relevant conditions. Sub-second 3D
MRI of these spin isomers can produce background-free functional lung images of gas diffusion and ventilation.
In this project, I will develop clinical-scale production of these spin isomers and their ultrafast MRI in excised
sheep lungs with the goal of systematic relaxation mapping for future in vivo studies. The clinical translation of
this new fast and low-cost imaging modality will revolutionize pulmonary imaging and pulmonary care of a wide
range of lung diseases—this is my long-term career goal.

Public health relevance
Project Narrative I propose developing next-generation ultrafast MRI to assess lung function using hyperpolarized propane gas as an inhalable contrast agent. The proposed low-cost and high-throughput technology for clinical-scale production of hyperpolarized propane can be employed for sub-second gas MRI, which we envision as a novel contrast agent for functional regional mapping of lung functions in a wide range of lung diseases. Here, I will study three contrast mechanisms in excised sheep lung model to demonstrate the robustness of this new quantitative 3D imaging method.